High-throughput screening to identify inhibitors of breast-to-brain metastasis

This project seeks to identify and develop small molecules that target breast-to-brain metastasis. 15-30% of women with stage IV breast cancer develop brain metastases, which negatively impacts life expectancy and quality of life. Small molecule chemotherapeutics that target these metastatic cells are of interest, however, there are a limited number of in vitro models available to identify and develop such therapeutic candidates.

During this period, the team focused on design, optimization, and implementation of a high-throughput screening amenable assay using breast-to-brain metastatic cells. Additionally, the team developed a maxtrix assay to identify small molecule combinations that would synergistically kill the brain-metastatic cells.